Research in Academic Pediatrics Initiative on Diversity (RAPID)

PROJECT SUMMARY/ABSTRACT
Minority children will likely outnumber white children by 2018. Unfortunately, pediatric workforce diversity
has failed to keep pace, especially in academia. Minorities comprise 49% of US children, but only 24% of US
pediatricians, and underrepresented minorities (URMs) make up only 11% of pediatricians and 8% of US
medical-school faculty. Despite this substantial mismatch, very little has been published on research
educational programs shown to be efficacious in recruitment and retention of diverse individuals pursuing
careers in the biomedical, behavioral, clinical, or social sciences. The Academic Pediatric Association (APA)
Research in Academic Pediatrics Initiative on Diversity (RAPID) is the first such research educational program
targeting faculty diversity in general academic pediatrics, and funding is requested for another five years.
The RAPID aim is to implement and evaluate a research educational program with the goal of successful
recruitment, retention, and professional advancement of diverse junior faculty in general academic pediatrics
pursuing careers in NIDDK mission areas. RAPID has several innovative components: 1) small research
grants in NIDDK mission areas using a model shown to be effective in promoting career development of young
investigators; 2) pairing RAPID scholars with national mentors who are accomplished senior investigators and
seasoned mentors; 3) in-person mentoring and networking at an annual breakfast at the Pediatric Academic
Societies meeting; 4) an annual career-development and leadership conference; and 5) monthly Scholar
telephone conference calls, to provide intensive mentoring, peer support, peer mentoring, networking, a venue
for presenting research in progress, and opportunities for potential research collaborations. The APA has
extensive available educational resources, experience, staff, and facilities, all of which will continue to ensure
the success of RAPID. The first five years of RAPID were highly successful, with the program achieving or
exceeding all original aims, including: 1) APA membership diversity significantly increasing; 2) multiple
Scholars obtaining four career-development awards; 3) Scholars generating multiple publications and
presentations at national conferences; 4) establishing a highly rated annual conference of URM investigators
from across the country spanning the spectrum from residents to mid-level faculty; and 5) convening an annual
networking breakfast of Scholars, National Advisory Committee members, and RAPID and APA leadership.
If, as anticipated, the hypotheses continue to be confirmed, RAPID will continue to result in: 1) successful
recruitment, retention, and professional advancement of diverse junior faculty researchers; 2) increased
likelihood that RAPID Scholars will present their project findings at a national professional meeting, publish
their project findings, obtain additional research funding, obtain a career development award, maintain their
APA membership, and highly rate their commitment to a research career in pediatric academic generalism;
and 3) a model societal program for enhancing the diversity of young investigators and their leadership skills.

Public health relevance
PROJECT NARRATIVE Minority children will likely outnumber white children by 2018, but pediatric workforce diversity has failed to keep pace, especially in academia, with minorities comprising 49% of US children, but only 24% of US pediatricians, and underrepresented minorities make up only 11% of pediatricians and 8% of US medical- school faculty. The Academic Pediatric Association (APA) Research in Academic Pediatrics Initiative on Diversity (RAPID) is the first research educational program targeting faculty diversity in general academic pediatrics, and an additional five years of funding is requested; the aim of RAPID is to design, implement, and evaluate a research educational program with the goal of successful recruitment, retention, and professional advancement of diverse junior faculty in general academic pediatrics who are pursuing careers in biomedical, behavioral, clinical, and social sciences consistent with NIDDK mission areas. If, as anticipated, the program continues to be highly successful, APA RAPID will result in: successful recruitment, retention, and professional advancement of diverse junior faculty researchers; increased likelihood that RAPID Scholars will present their project findings at a national professional meeting, publish their project findings, obtain additional research funding, maintain their APA membership, and highly rate their commitment to a research career in pediatric academic generalism; and a potential model societal program for enhancing the diversity of young investigators and their leadership skills.